AG Bell Global Listening & Spoken Language Symposia

AG Bell’s annual AG Bell Global Listening and Spoken Language Symposium in 2022, 2023, and 2024 will
each include four keynote presentations that focus on the sharing of high-impact research that will impart a
fuller understanding of specific issues related to childhood hearing loss and, as appropriate, practical
application to the population of children with hearing loss. The primary goal is to inform researchers, clinicians,
other professionals, family members, and other stakeholders of the benefits of various interventions to improve
child outcomes related to hearing loss, speech and language, social and emotional, education and health.
Specific aims for the Research Forum and related activities include:
Aim 1) to provide clinicians/researchers with clinically and educationally relevant research in oral presentations
by professionals who are involved in cutting-edge work applicable to immediate and/or future interventions with
children and others who are deaf or hard of hearing;
Aim 2) to provide the public with open access to recorded keynote sessions (captioned and available in
spoken English and Spanish) on AG Bell’s website so that clinicians/researchers, other professionals,
parents/family members and individuals who are deaf or hard of hearing, who may not have been in
attendance at the AG Bell Global Listening and Spoken Language Symposium, have the opportunity to learn
about current research;
Aim 3) to provide attendees and the public with open access to a written proceedings document to support
learning that was initiated at the symposium during keynote sessions and that could improve short-term and
long-term outcomes of children when translated to clinical and educational environments;
Aim 4) to provide students interested in pursuing research careers with funding that will support their learning
about pediatric hearing loss, listening and spoken language and related issues; and
Aim 5) to create a video, “Taking the Mystery Out of Research,” and provide open access to this tool on AG
Bell’s website so that parents, other caregivers, individuals who are deaf or hard of hearing and others as
active consumers, may better understand and appropriately apply evidence-based information to one’s own
self, child and/or family and know what tools exist for locating high-quality data and research information.
The three symposia will focus on the following research topics on hearing loss:
2022: Hot Topics that Impact Outcomes for Children who are Deaf or Hard of Hearing, Virtual
2023: The Impacts of Identification and Intervention on Children who are Followed Longitudinally in
Australia, Hybrid Symposium, Brisbane, Australia.
2024 – Predicting Outcomes through Knowledge and Optimization of Application of Interventions for
Children who are Deaf or Hard of Hearing, Hybrid Symposium, Portland, Oregon.

Public health relevance
The effects of hearing loss and deafness is a global health issue that knows no borders – over 466 million people are affected by hearing loss and 34 million of them are children. Lack of information and resources prove to be the main obstacles toward their success in developing language, and among those who most need the information on advances in hearing health research and therapy are professionals in Listening and Spoken Language. The AG Bell Global Symposium ensures that these professionals have the latest information on research that is changing deafness across the globe.